Seattle Children's Urologic Management to Preserve Initial Renal Function Protocol for Young Children with Spina Bifida (UMPIRE Protocol) (Component C)

0MB Number: 4040-0001
Exnlratlon Date: 10/3112019
APPLICATION FOR FEOERAL ASSISTANCE
SF 424 (R&R)
1. TYPE OF SUBMISSION
D Pre-application cg] Application D Changed/Corrected Application
2. DATE SUBMITTED
I I
3. DATE RECEIVED BY STATE
I I
4. a. Federal Identifier
b. Agency Routing Identifier
c. Previous Grants.gov
Applicant Identifier
I
State Application Identifier
Tracking ID
5. APPLICANT INFORMATION Organizational DUNS: lo486821s10000 I
·
Legal Name: jseattle Children I s Hospital I
Department: [ I Division: I I
Street1: l·soo Sand Po~nt Way NE I
Street2: f I
City: lseattle ICounty I Parish: I I
State: I WA: Washington I Province: I I
Country: I USA: UNITED STATES I ZIP / Postal Code: 198105-3901 I
Person to be contacted on matters !nvolvlng this application
Prefix: lor. I First Name: !James I Middle Name: IB. I
Last Name: [Hendricks . 1 Suffix: I
Pos!tionffitle: !President, Research Institute I
Street1: j1900 Ninth Avenue I
Street2: IM/S 818-S I
City: lseattle ICounty I Parish: [King I
State: I WA: Washington I Province: I I
Country: I USA: UNITED STATES IZIP/ Postal Code: 198101-1309 I
Phone Number: 1206-884-7478 I Fax Number: 1206-884-1597 I
Email: [email] I
6. EMPLOYER IDENTIFICATION (EIN) or/TIN): 191-0564748 I
7. TYPE OF APPLICANT: f M: Nonprofit with 501C3 IRS Status (Other than Institution of Higher Education)
I
Other (Specify): I l
Small Business Organlzation Type D Women Owned D Socially and Economically Disadvantaged
If Revision, mark appropriate box(es).
DA. Increase Award DB. Decrease Award c. Increase Duration DD. Decrease Duratton
DE. Other (specify):I I
8. TYPE OF APPLICATION:
cg] New D Resubmission
D Renewal D Continuation Revision
Is this appllcatlon being submitted to other agencies? Yes O No rgj What other Agencies? I
9. NAME OF FEDERAL AGENCY:
!Centers for Disease Control and Prevention -
ERA
10. CATALOG OF FEDERAL DOMESTIC ASSISTANCE NUMBER:!93. 315
TITLE: IRare Disorde:i:·s: Research, Surveillance, Health Promotion,
and Education
11. DESCRIPTIVE TITLE OF APPLICANT'S PROJECT:
!Seattle Children's Urologic Management to Preserve Initial Renal Function Protocol for Young Children with Spina
Eifida (UMPIRE Protocol) (Component C}
12. PROPOSED PROJECT:
Start Date Ending Date
I 09/01/2019 11 0013112024
13. CONGRESSIONAL DISTRICT OF APPLICANT
lwA-007 II
9001050 11
SF 424 (R&R) APPLICATION FOR FEDERAL ASSISTANCE Page 2
14. PROJECT DIRJ;CTOR/PRINCIPAL INVESTIGATOR CONTACT INFORMATION
Prefix: -~r. I First Name: lwilliam I Middle Na~m_e_:_Ll:,o=t=i=s===;--------'I
Last Name: 11!'.w;al'.:k=·=r================,------'lSuffix: cclJ"-r'-.- - - ~ '
Position/Title: IL---;:===============:_I_____-----,
Organization Name: jseattle Children I a Hospital I
Pepartmen.:t:11::============c.._l_:D:_:iv:_:is:_:lo_n_:"=====;--------'I
Street1: [4a()o sand J?oint Way NE I
Street2:, I I
s============;-:--:--~~==--------
CIty: lseattle j County/ Parish: I I
State: I WA, Washington j Prmilnce: l'------;===========lc..__~
Country: ~,=====,====U=SA=,=UN::'I::'T::'E::'D::'S:::T::'A::'TE=S========;Z-'I,P/ Postal Code: "'9-'8"-0l'-5'---..C.3_90__1 _ _ _ _ _ _ _~1
Phone Number: j206-981-2000 j Fax Number: 1206-987-7818 I
Email: lwilliam. walker@seattlech>ildrens ,org
16. IS APPLICATION SUBJECT TO REVIEW BY STATE EXECUTIVE ORDER
12372 PROCESS?
a. YES O TNIS PREAPPLICATION/APPLICATION WAS MADE
AVAILABLE TO THE STATE EXECUTIVE ORDER 12372
PROCESS FOR REVIEW ON:
DATE: I I
b. NO [8;l PR~.GRAM IS NOT COVERED BY E,O. 12372; OR
 PROGRAM HAS NOT BEEN SELECTED BY STATE FOR
REVIEW
15. ESTIMATED PROJECT FUNDING
1-------------;::========;-I
a. Total Federal Funds Requested I 102, 495_ ool
b. Total Non~Federal Funds I o.ool
c. Total Federal & Non·Federal Funds I 102,495.001
d, Estimated Program Income I o. ool
17. By signing this application, I certify {1) to the statements contained in the list of certifications* and (2) that the statements herei~ are
true, complete and accurate to the best of my knowledge. I also provide the required assurances* and agree to comply With any resulting
terms if I accept an 'award. I am aware that any false, fictitious. or fraudulent statements or claims may subject me to criminal, civil, or
administrative penalties. (U.S. Code, Title 181 Section 1001)
~ I agree
*The llsf of certifications and assurances, or an Internet site where you may obtain this /Isl, Is contained In tho announcement or agency specific instructions.
18. SFLLL (Dfsclosure of Lobbying Activities) or other Explanatory Documentation
lrl.~. ~/-id~)~,,~\t=~c~b~.in-e~Qt-,·~11 )ji,1~te/\Uaq1Jrni,of·.11 ·· Vi~WAitaclirrteni ·. I
19. Authorized Representative
Prefix: lor. I First Name: !James I Middle Name: la. I
~-====::::;------'
Last Name: !Hendricks 7 Suffix: I I
'--;:::==============~----' '------1
Pos1tlon[fltle: !President, Research Institute I
Organization: [seattle children 1 s Hospital
Department l~===========:'_ID_1v_1s_1o_n_,:======:;--_____Jl
Street1: 11900 Ninth Avenue !
Street2: IM/S 818-s I
~_2::===========,--:-::-:--====!...-----
City: lseattle ! County/ Parish: I I
State: I WA, Washington I Province: I I
Country:·'-;1=======::::0S=A=,=U=N=I=T=ED=S=TA=T=E=S=========:C::1 ZIP I Post'.:a:-:1C::-o:-:d::-e_~,;:::9=81=0=1=-=13=0=9======'---~,
Phone Number: !206-884-7478 I Fax Number: !206-884-1597 !
Sitmature of Authorize ~1,~;;;;;;;=~-~I Date Signed
Email: lresadmin@seattiechildrens, or
,~·.,. ,,,/,/, / . ;/S 9: C . Aotlnpil'l~~half o( ... I .'3·/,~--··· }It>.
" 4 / ~ ·l.C ····.. ·· .Jarp~fi·~. l::lendricki,, !'hD,Pres dent . ·1
20. Pre-application I~==============~ l~~d~t!ll<llil)1e6t 11 Del~i~A1t~chljii,iiti I' \/le,W/\tfa~fai~ertt J
21. Cover Letter Attachment le Cover Letter 2019. pd£ 11;.AM'Maohriient I loelet~)l.ttacllrrifjj] 11,~wAttaqh!iJen(I
I
Seattle Children's
HOSPITAL · RESEARCH · FOUNDATION
Division of Developmental Medicine
Department of Pediatrics
Seattle Children's Hospital
January 23, 2019
Office of Grant Services
Centers for Disease Control and Prevention
2920 Brandyv,,ine Road, GHSecB, Team 1
Atlanta, GA30341
RE: RFA-DD-19-001
To Whom It May Concern:
Please accept this proposal entitled "Urologic Management to Preserve Initial Renal Function Protocol for
Young Children with Spina Bifida" (UMPIRE Protocol). This proposal is being submitted in response to the
recent RFA-DD-19-001 entitled "Research Approaches to Improve the Care and Outcomes of People Living
with Spina Bifida".
Please contact me at the phone number or email address belowwith any questions regarding this proposal.
Thank you,
William 0. Walker, Jr. MD
Chief, Division of Developmental Medicine
Robert A. Aldrich Endowed Professor, Pediatrics
University ofWashington School of Medicine
Seattle Children's Hospital
Phone 206-987-2590
FAX 206-987-3824
William .[email]
Contact PD/Pl: Walker. William 0
424 R&R and PHS-398 Specific
Table Of Contents
SF 424 R&R Cover Page ............................................................................................................1
Table of Contents...................................................................................................................3
Performance Sites.....................................................................................................................4
Research & Related Other Project lnformation......................................................................6
Project Summary/Abstract(Description) ..............................................................................7

Public health relevance
Project Narrative....................................................................................................................8 Facilities & Other Resources ................................................................................................9 Research & Related Senior/Key Person ................................................................................12 Research & Related Budget Year - 1......................................................................................25 Research & Related Budget Year - 2......................................................................................28 Research & Related Budget Year - 3......................................................................................31 Research & Related Budget Year - 4......................................................................................34 Research & Related Budget Year - 5......................................................................................37 Budget Justification ................................................................................................................40 Research & Related Cumulative Budget...............................................................................43 PHS398 Cover Page Supplement. ..........................................................................................44 PHS 398 Research Plan ...........................................................................................................46 Specific Aims ........................................................................................................................47 Research Strategy................................................................................................................48 Progress Report Publication List. ......................................................................................60 PHS Human Subjects and Clinical Trials lnformation......................................................61 Study 1: Urologic Management to Preserve Initial Renal Function Protocol for Young Children with Spina Bifida (UMPIRE Protocol)..............................................................63 Inclusion Enrollment Reports......................................................................................69 Bibliography & References Cited.......................................................................................77 Letters of Support................................................................................................................78 Resource Sharing Plan(s) ...................................................................................................79 Table of Contents Page 3